Structural Basis for KCNE Modulation of the KCNQ1 Channel

DESCRIPTION (provided by applicant): The human KCNQ1 voltage-gated potassium channel is modulated by interactions with an accessory subunit, KCNE1, a process that is essential for healthy cardiac and auditory function. Mutations in KCNQ1 and KCNE1 result in congenital long QT syndrome (LQTS) and some forms of deafness. KCNE1 acts both to slow down voltages-stimulated channel activation and also dramatically enhances the conductance of the open state. Other KCNE family members exert radically different changes in KCNQ1 channel function. In the upcoming phase of this project the aims are: Aim 1. Use NMR to determine the 3-D structure of KCNE1 under conditions in which it is solubilized in actual lipid bilayers. This aim will test whether the structure of KCNE1 we recently determined in classical micelles represents the bona fide structure of the protein in lipid bilayers, or whether elements of the determined structure that were crucial in formulating our working model for KCNE1 function were, in fact, artifacts of working in micelles. Aim 2. Using mutagenesis of both KCNE1 and KCNQ1, biochemical measurements, and electrophysiological recordings of KCNQ1 channel properties, critically evaluate and refine the current working model for how KCNE1 slows down KCNQ1 channel opening and enhances open state conductance. Aim 3. Determine the 3-D structure of KCNE3 in bilayers and formulate a working model for how KCNE3 rapidly activates Q1 channel function. Aim 4. Carry out structure-function and biochemical testing/refinement of the new model for how KCNE3 rapidly activates KCNQ1 channel function. Aim 5. Determine the structure of KCNE4 in bilayers and formulate a working model for how KCNE4 inhibits KCNQ1 channel function. PUBLIC HEALTH RELEVANCE: Studies are being undertaken of the structures and interactions of the human KCNE1, KCNE3, and KCNE4 proteins with the KCNQ1 potassium channel in order to determine how these KCNE family proteins modulate the function of this channel, as can occur in an aberrant manner that causes certain forms of deafness and heart disease.

Public health relevance
Project Narrative Studies are being undertaken of the structures and interactions of the human KCNE1, KCNE3, and KCNE4 proteins with the KCNQ1 potassium channel in order to determine how these KCNE family proteins modulate the function of this channel, as can occur in an aberrant manner that causes certain forms of deafness and heart disease.